Method for the validation by Western analysis of affinity reagents against post-translationally modified proteins.

ABSTRACT
Antibodies (Abs) are commonly employed in biomedical research to identify and quantify target
proteins. However, the specificity, sensitivity and reliability of these Abs can be variable, which is a
significant concern in the scientific community. The use of an incorrect Ab can result in misleading
or inaccurate results, impeding progress in various areas of biomedical research. In Phase I of this
project, we developed tools to validate the specificity of commercial Abs used to detect
phosphorylated sites in proteins in a method we developed and published that we named
MILKSHAKE. We will present some of these results from this Phase I effort, which demonstrates the
critical need to address this concern. This proposed SBIR Phase II project aims to both extend and
commercialize the Phase I effort. We will continue the Ab validation work initiated in Phase I by
extending the analysis to other types of post-translational modifications (PTMs) of proteins in
Western analysis and flow cytometry. This Phase II project also seeks to improve and scale this
pipeline further, and to develop new methods for validating Abs against glycosylated proteins, which
are often dynamic and challenging to detect using traditional techniques. We will also employ an
innovative tool for measuring Ab promiscuity using a technology we term ‘Sundae’ to better
investigate the specificity of the Ab paratope. Sundae will be demonstrated for two therapeutic Abs.
The Phase II project has several key objectives, including the development of new Ab-specific
assays and the establishment of a centralized database for sharing validated Ab data. The project
team comprises experts in Ab validation, proteomics, and molecular biology, and will collaborate
closely with our current and future industry partners and academic researchers to ensure our
success.

Public health relevance
NARRATIVE While there are already some established methods for antibody validation, there are still issues with the specificity, cross-reactivity, reproducibility, sensitivity, and accuracy of them. This is especially true for antibodies directed against post-translationally modified proteins. The proposed Phase II effort aims to address these issues by investigating the effects of post-translational modifications, comparing our MILKSHAKE method with other established methods for quantifying specificity and sensitivity, using our Sundae method for evaluating the importance of paratope specificity, and our Epivolve method for the discovery and validation of glycosylation-specific antibodies. The proposal also includes a means for the dissemination and commercialization of this Phase II project, which will increase the impact of this effort. Overall, the proposed research has the potential to contribute to the development of more reliable and accurate antibody validation methods and improve the reproducibility of biomedical research.